Intergenerational transmission of threat sensitivity as an risk marker for psychopathology in young children

PROJECT SUMMARY
Characterizing neurocognitive risk parameters in children is critical to the study of developmental
psychopathology and paves the way for novel treatment and interventions. Heightened threat sensitivity – the
recognition, interpretation, and response to real or potential threat cues in the environment – is a strong
neurocognitive predictor of anxiety risk. However, little is known about how heightened threat sensitivity
develops and is maintained across time. The limited extant work suggests parental characteristics and
behaviors influence children's anxiety risk and may shape the development of children's threat sensitivity.
However, we lack knowledge about intergenerational influences on the transmission of heightened threat
sensitivity. The current study uses a longitudinal intergenerational framework to identify factors that influence
the neural, biological, and behavioral correlates of threat sensitivity across time and generations.
The current project will be the first intergenerational study of the Philadelphia Neurodevelopmental Cohort
(PNC), a racially-diverse cohort of ~10,000 participants assessed at age 8–21 between 2009-2012, with many
participants becoming parents in the last 5 years. In 300 mother-child dyads (children aged 4-8 years), we use
a multimethod assessment framework with psychiatric (clinical interview, self-report), behavioral (computer
tasks), observational (parent-child interactions), neural (electroencephalogram: EEG), and physiological
(electrocardiogram: respiratory sinus arrhythmia) measures to examine the pathways underlying longitudinal
and intergenerational influences on threat sensitivity and anxiety. First, we leverage data from the original PNC
to examine factors that influence the presence of a multimethod threat sensitivity construct in mothers, 10-
years later, and examine longitudinal links between threat sensitivity and anxiety symptomatology. Second, we
focus on the child's threat sensitivity and anxiety, investigating the intergenerational influence of maternal
threat sensitivity and, in an available subsample, the influence of paternal/secondary caregiver (n=200) threat
sensitivity, on the child's threat sensitivity and anxiety. The study also examines the role of environmental
threat exposures (e.g., trauma, discrimination, and poverty) on individual differences in threat sensitivity, with
the hypothesis that increased threat exposures will increase susceptibility to abnormal threat processes. Lastly,
we investigate a possible mechanism underlying the intergenerational transmission of threat sensitivity:
negative parental communication. We will examine real-time transmission of threat through parental
communication (e.g., verbal threat promotion, expressed anxiety) across a series of parent-discussion tasks.
This project aligns with NIMH programmatic goals by charting mental health symptoms and mechanisms of
risk across the lifespan. Results from the multimethod approach will inform multisystem mechanisms of
intervention and prevention at the level of the parent and child. Our proposed expansion of the PNC to a
longitudinal intergenerational cohort is an unprecedented opportunity to transform knowledge on anxiety risk.

Public health relevance
PROJECT NARRATIVE Heightened threat sensitivity – the recognition, interpretation, and response to real or potential threat cues in the environment – is a strong neurocognitive predictor of anxiety risk across the lifespan, yet little is known on how individual differences in threat sensitivity develop. Following 300 racially diverse women and their 4–8- year-old children, the current project uses an intergenerational, multimethod approach to examine links between threat sensitivity and anxiety across generations and investigate how environmental exposures affect this link. Findings from this project will advance our knowledge about the intergenerational transmission of threat sensitivity and risk for anxiety disorders and inform targets for intervention and prevention at the level of parent and child.